Self-Powered Load Sensors for Total Knee Replacement Health Monitoring

The goal of this research is to make a prototype of a self-powered load sensing system for Total Knee
Replacement (TKR) and show its effectiveness via pre-clinical testing on cadaver knees under simulated
activities of daily living. TKR is the most common surgery, and it is growing in numbers because of the
osteoarthritis epidemic in older people and sports accidents in younger people. During joint replacement
surgeries, prosthesis are aligned to provide appropriate kinematics and stability. Unfortunately, aberrant loading
patterns resulting from implant misalignment or ligament imbalance after surgery can result in early failure.
Tracking the long-term health of the implant is difficult without quantitative joint load data. This is especially true
for telehealth, which have become increasingly common due to restrictions on in-person clinic visits as a result
of the COVID-19 pandemic. The ability to noninvasively measure loads using embedded autonomous sensors
would enable earlier identification of aberrant loading and the development of treatment strategies.
State-of-the-art technologies use electromagnetic or piezoelectric transducers. Electromagnetic devices require
incorporation of a coil and magnets within the prosthesis, which may weaken the structure. Piezoelectric
transducers, on the other hand, are most commonly made of ceramics that contain lead posing obvious health
risks. Lead-free Piezoelectric materials have been made, but they have lower power density, especially
compared to newer energy harvesting technology. Triboelectric energy harvesting is a newly discovered energy
harvesting technique based on contact electrification and electrostatic induction. Triboelectric energy harvesters
convert cyclic motion to electricity by generating charges at micro-patterned textured contacting surfaces. The
wide range of materials that exhibit triboelectric properties allows flexibility in the design of harvesters for low
cost, high sensitivity, high power density and biocompatibility, making them ideal for implant applications.
To take advantage of this promising new technology, we propose a self-powered load monitoring system for
TKR that can be customized and installed between the ultra-high molecular weight polyethylene (UHMWPE)
bearing and the tibial tray, allowing the device to be incorporated into any TKR system. The load monitoring
system comprises four harvesters, one in each quadrant of the tibial tray, and a frontend electronics system. The
system can monitor the force distribution across four quadrants over time. This information is essential in health
monitoring of the implant because aberrant load transmission is a leading cause of implant revision surgeries.
The amount of energy harvested is small (~20 microwatts), but is adequate for extracting important features of
the load throughout the day. The data will be gathered on a computer and normal versus abnormal loading
patterns will be classified using artificial neural networks. This creative approach enables the sensor to
continuously operate using solely the power produced by the harvester. The proposed project can revolutionize
the biomedical implant field by providing quantitative data that can guide health care decision making.

Public health relevance
Integrated load sensing in total knee replacement implants would allow for early warning of load-related failures or other biomechanical problems, but powering such devices is an ongoing challenge. We propose a load measurement system that is self-powered using energy harvested from joint forces during activities of daily living. The goal of this research is to design, manufacture and test prototype self-powered sensors in realistic in vitro loading conditions as a step towards clinical applications.